The GCE4All Center: Unleashing the Potential of Genetic Code Expansion for Biomedical Research

EQUIPMENT SUPPLEMENT ABSTRACT
The GCE4All Biomedical Technology Development and Dissemination Center at Oregon State University (OSU)
serves to optimize, develop, and broadly disseminate Genetic Code Expansion (GCE) technology – the
engineering of cellular translation to express proteins containing non-canonical amino acids (ncAAs). During its
envisioned lifespan of ≤15 years, the Center's mission is to effectively extend existing GCE technologies for facile
use by non-specialists, and to broadly disseminate them via widespread education, effective training, and by
providing sustainable access to optimized technologies via established repositories – enabling powerful GCE
approaches to become standard, widely-used tools of biomedical researchers. As we build new GCE encoding
systems, quantifying the intact mass of the ncAA-proteins is critical to verify the site-specific encoding of ncAAs,
to verify that there is no loss in fidelity by mis-encoding of natural amino acids, and to evaluate biorthogonal
labeling reactions on proteins. However, the center does not have equipment to characterize intact protein mass.
The university MS facility has two MS systems capable of intact protein mass characterization, an old Waters Q-
Tof MS system soon to be decommissioned and a high res-Q-TOF Lumos system. This facility unfortunately is
not able to provide the daily or weekly access for analysis of intact protein mass needed by the center and they
cannot accommodate walk up service from center staff. Here, we request funds to acquire a benchtop MS system,
6230B TOF MS system with ESI source and 1290 LCMS system with autosampler from Agilent. A center housed
MS system capable of intact protein mass analysis would allow us to quickly evaluate proteins from the center
and DBP labs. We expect the instrument will serve 50-100 researchers per year, including all personnel in the
center, DBP collaborators and 2 workshops of 20 people per year. A permanent center staff member will be
assigned to MS equipment maintenance and user training. The in-house ability to run and process our own intact
protein MS analysis on a daily basis will greatly accelerate the center mission regarding GCE technology
development, optimization and dissemination for DBPs and GCE trainees.
The summary of our original grant is included in our research strategy document.

Public health relevance
Narrative for Genetic Code Expansion Center The Genetic Code Expansion Biomedical Technology Development and Dissemination Center will allow biomedical researchers around the world to have access to better scientific tools to generate specially designed forms of proteins for probing and visualizing how life works. This will help them better determine how and where biological processes go wrong to cause cancer, heart disease, pain, diabetes, Parkinson's disease, and many other diseases, and will also drive new innovations and enable the development of more sensitive and specific diagnostic tests and more effective drugs.